Acute Prenatal Alcohol Exposure Potentiates Conotruncal Defects in the Setting of a Permissive Genetic Background

PROJECT SUMMARY/ABSTRACT
Nearly 30% of patients with Fetal Alcohol Spectrum Disorder (FASD) have a congenital heart defect
(CHD). Outflow tract (OFT) defects are over-represented, though with variable incidence and severity. The
majority of prenatal alcohol exposure (PAE) research focuses on the hallmarks of FASD, chronic drinking and
neurologic defects. The most common form of PAE in the population, acute exposure during the
periconceptual period, and its effect on cardiac development have not been studied. We will study the effects
of acute, periconceptual drinking both through a multi-institutional clinical study and with our acute PAE murine
model, in which mice receive two intraperitoneal injections of 3g/kg of 30% ethanol at a point critical to cardiac
organogenesis. We hypothesize the variable incidence and severity of PAE-induced OFT defects can be
explained by a combination of PAE and otherwise non-deleterious mutations that result in a genetically
permissive background. We believe mutations in the Notch pathway establish such a genetically permissive
background, and that PAE acts synergistically with these mutations via epigenetic regulation of Notch to result
in OFT malformation. Aim 1 of this study will address the specificity of the deleterious effects of PAE to OFT
alignment and define the molecular pathways disrupted in individuals with PAE-induced OFT defects. We will
achieve this through relative risk analysis of PAE and CHD diagnoses and pathway and subsequent logistical
regression analyses of whole genome sequencing data. Aim 2 will define alcohol driven epigenetic regulation
as the mechanism by which acute PAE and otherwise non-deleterious Notch pathway mutations synergistically
disrupt OFT development. Using a combination of molecular assays and histologic analysis in vitro and in vivo,
we will test the impact of this combined teratogenic insult on second heart field (SHF) viability and ability to
migrate into the OFT. We will establish PAE driven epigenetic regulation, disrupting Notch gene accessibility
and transcription, inhibits Notch signaling and use a pan-histone acetyltransferase inhibitor in vitro to
demonstrate prevention of PAE induced hyperacetylation is sufficient to rescue Notch signaling and SHF
viability. Similarly, rescue of SHF viability by overexpression of notch intracellular domain (NICD) in vitro will
cement the point of acute PAE and Notch mutation synergy as loss of Notch signaling prohibiting SHF viability.
As one of the first studies to examine the interaction of clinically relevant acute PAE with heart
development, this study addresses the priorities of the NIAAA to define the impact of non-chronic exposure
and alcohol’s effects on understudied organ systems. The genetic pathways identified by this study, including
novel validation of the Notch pathway as significant in PAE-induced CHD, will provide targets for disease
prevention and identification of those most at risk to develop the world’s most common and deadly birth defect.
Completion of this project is ensured by the technical training and mentorship by the sponsorship team, the
training site’s cutting-edge facilities, and education provided by the principal investigator’s M.D.-Ph.D. program.

Public health relevance
PROJEC NARRATIVE The root cause for the majority of cases of congenital heart defects (CHD) cannot be explained by current research. There is an established risk for alcohol use during pregnancy resulting in CHD without mechanistic understanding of how alcohol disrupts heart development. This fellowship will allow for investigation into a large, modifiable CHD risk factor, paving the way for therapeutic and preventative interventions to reduce the leading cause of newborn death and driving cost for pediatric hospitalizations.